Understanding the relationship between individual, social, and structural determinants of health, mobility, and HIV outcomes among adolescents and young adults living with HIV in Tennessee

ABSTRACT
Adolescents and young adults living with HIV (AYA-HIV), especially minoritized individuals, face the highest
HIV incidence and poorest care outcomes among all age groups of people living with HIV (PWH) in the United
States. Mobility has emerged as a critical driver of these disparities, but research in the US context is limited.
The convergence of younger age and mobility poses a significant challenge to individual and public health
efforts to address care inequities and end the HIV epidemic in the US. Our preliminary work in Tennessee,
which includes Memphis/Shelby County, an End-the-Epidemic priority region, found that PWH change
addresses nearly four times more often than the general population, with higher frequency among AYA-HIV.
Mobile PWH were more likely to be lost from care, and mobility patterns followed recurring spatial pathways
suggesting structural determinants. Our central hypothesis is that social and structural determinants of health
(SSDOH) are associated with distinct mobility phenotypes among AYA-HIV that differentially impact HIV care
outcomes. To build on these critical findings and test this hypothesis, our experienced, multidisciplinary team
will assemble a prospective cohort of 300 AYA-HIV in Tennessee. We will use a mixed-methods approach
integrating robust individual- and population-level geospatial analyses to accomplish three Aims: 1) Determine
patterns of personal mobility and multilevel factors contributing to mobility among AYA-HIV in TN; 2) Evaluate
how personal mobility impacts HIV care outcomes among AYA-HIV; 3) Assess the relationship between
SSDOH on the prevalence and patterns of residential mobility among all AYA-HIV in TN and the role of
mobility as a mediator of the relationship between SSDOH and HIV care outcomes (LTFU, retention and viral
suppression). For Aims 1 and 2, we will a) passively monitor personal mobility of cohort members over 18
months via a global positioning system (GPS)-enabled mobile phone application, b) integrate geospatial
analyses with data-informed in-depth interviews (IDIs) with AYA-HIV exhibiting potentially distinct mobility
patterns (n≤30 every 6 months) to describe mobility phenotypes, and c) utilize qualitative and statistical
methods to describe mobility phenotypes, elucidate factors driving personal mobility and assess the
relationship between mobility phenotypes and HIV care outcomes. For Aim 3, we will use population-level
geospatial methods combined with HIV surveillance and census data from the TN Department of Health to
explore neighborhood-level SSDOH as drivers of residential mobility, and the relationship between mobility and
HIV care outcomes for all AYA-HIV in the state. This pioneering study will provide a rigorous, multilevel
understanding of mobility among AYA-HIV in the US. By elucidating how social and structural factors drive
mobility and its downstream impact on health, we will lay the foundation for developing tailored interventions to
address this critical barrier to ending the HIV epidemic, with implications for other chronic conditions.

Public health relevance
PROJECT NARRATIVE This five-year study aims to understand how social and structural determinants of health influence mobility patterns among adolescents and young adults living with HIV (AYA-HIV) in Tennessee, and how these patterns influence HIV care outcomes. Through a mixed-methods approach – integrating geospatial monitoring, in-depth interviews, population-level data, and clinical data – we will examine how personal and residential mobility affects HIV care outcomes. Elucidating these relationships will inform the development of targeted interventions to address disparities among mobile AYA-HIV and contribute to efforts to end the HIV epidemic.